The UC DPP Study: Evaluating a Diabetes Prevention Initiative Across the University of California System

PROJECT SUMMARY/ABSTRACT
To address obesity and type 2 diabetes prevention across all University of California (UC) campuses, a new
UC-wide Diabetes Prevention Initiative (referred to as the UC DPP Initiative) was launched in 2018. In an
innovative scientific partnership between researchers and the university, the UC Office of the President will
provide access to electronic health record (EHR) and insurance claims for UC beneficiaries, as well as
campus-level data across five UC campuses to conduct a rigorous evaluation. We will use a well-established
reach, effectiveness, adoption, implementation, and maintenance (RE-AIM) evaluation framework to ensure a
comprehensive evaluation. To assess the effectiveness of the UC DPP Initiative, we will examine mean
percent weight change at 12-months (primary outcome) and 24-months within and between overweight/obese
UC beneficiaries at risk for type 2 diabetes. To assess reach, we will report the proportion of eligible UC
beneficiaries who engage in DPP (attend >9 and >16 sessions) and their representativeness of UC
beneficiaries overall. To examine adoption, implementation and maintenance, we will conduct site visits and
qualitative interviews, focused on assessing the degree of implementation, identifying barriers and facilitators
associated with implementation, and unanticipated consequences. In summary, this is a unique opportunity to
conduct an imperative evaluation using diverse data sources across the UC system. Findings from this study
will inform future UC-wide programs targeting obesity and type 2 diabetes prevention, as well as dissemination
of effective strategies to other large university systems and employers.

Public health relevance
PROJECT NARRATIVE This project will evaluate the reach, effectiveness, adoption, implementation and maintenance of the University of California (UC) system-wide Diabetes Prevention Initiative launched to address obesity and type 2 diabetes prevention for faculty and staff across five diverse UC campuses.